Palliative Care Research Cooperative Group (PCRC): Measurement Core

PROJECT SUMMARY/ABSTRACT
The primary goals of this U2C application are to increase the productivity and impact of the Palliative Care
Research Cooperative Group (PCRC) through facilitating conduct of high-quality, effective clinical research
and expanding the number and expertise of palliative care researchers conducting multi-site clinical trials. In
pursuit of these overall goals and objectives, the Measurement Core, one of four Cores within the PCRC,
strives to facilitate progress in EOLPC research by ensuring high quality measurement science and patient-
centered outcomes in all PCRC supported research protocols, and by promoting investigator development and
training in measurement science. The Measurement Core's specific aims are: (1) to continue to expand the
PCRC Instrument Library to meet emerging needs of EOLPC research; (2) to foster the development and
validation of instruments that meet the needs of EOLPC research, with a particular focus on underrepresented
minorities and those who are economically disadvantaged, those with multiple chronic conditions, and pediatric
populations; (3) to lead the review, revision and expansion of the PCRC Common Data Elements in
collaboration with other Cores (Data, Informatics, and Statistics; Caregiver Research; and Clinical
Studies/Methodology); (4) to collaborate with the other three Cores to create consistency across studies that
consult with the PCRC and promote synergy among the Cores; and (5) to work closely with the Investigator
Development Center to mentor and train PCRC members in the rigorous use and development of measures in
their study design. The Measurement Core specific aims and strategies are intended to provide a
methodologically rigorous and multi-faceted approach to meeting the measurement needs of EOLPC research.